Microglia-neuron dopamine signaling - a novel mechanism of dopamine circuit modulation

Project Summary
This proposal will explore a new axis of dopaminergic regulation–microglial expression of the dopamine
receptor DRD1 and their modulation of neuronal activity and excitability in response to changing dopamine
levels. Microglia, the resident immune cells of the central nervous system, exhibit a wide array of functions,
some stereotypical of macrophages and some unique to the brain. Recent research from our lab and others
has demonstrated that one such function is to modulate neuronal activity, but how and why they do so is still
under investigation. Microglia exhibit a high degree of regional heterogeneity in form and function, perhaps to
account for the diversity of local cues and demands of different brain regions. A growing body of literature
suggests that microglia possess the ability to express receptor transcripts for and respond to an array of
neurotransmitters and neuropeptides, and that expression of these may vary by region, activity, or disease
state. Our lab has uncovered a unique subpopulation of microglia that express the dopamine receptor DRD1
(D1) in the striatum. Dopamine is a neurotransmitter involved in reward, motivation, voluntary motor behavior,
and substance use disorders. How, when, and why microglial DRD1 expression emerges remains unclear, and
I will confront each of these questions with my proposed experiments. I will trace the ontogeny of microglial
DRD1 through development using several transgenic mouse models to investigate when microglial DRD1
expression begins, from where D1+ microglia originate, if not the striatum, and if expression/maintenance is
dependent upon dopaminergic input. I will also use cutting-edge microglia transplant techniques to determine if
microglia can acquire DRD1 in the striatum, which will provide important evidence for the role of local cues in
microglial phenotypic determination, an open question in the field. Additionally, preliminary data from our lab
have demonstrated that D1+ microglia may be able to modulate the neuronal and behavioral response to
dopamine. Ablation of microglia overall and D1+ microglia specifically both amplify the locomotor response to
chronic cocaine, which increases dopamine levels by blocking reuptake. Changing dopamine levels are
characteristic of a number of physiological, developmental, and environmental events. In this proposal, I will
explore two that are associated with an adaptation of striatal medium spiny neuron excitability: juvenile
dopaminergic development and chronic cocaine. Based on our data, I hypothesize that D1+ microglia sense
and respond to dopamine in order to tune neuronal excitability to changing dopamine levels throughout the
lifetime. Exploring the role of D1+ microglia in dopaminergic signaling is critical to understanding the
dopaminergic dysfunction that characterizes numerous neuropsychiatric and neurological disorders, including
substance use disorder, Parkinson’s disease, depression, and ADHD, and could provide novel therapeutic
targets for those that have thus far found few effective treatment options.

Public health relevance
Project Narrative Research regarding the dopaminergic system, which is highly involved in reward, voluntary motor behavior, and substance use disorders, has long focused on neurons. With evidence that microglia can modulate neuronal activity and the discovery of a novel subpopulation of microglia expressing the dopamine receptor DRD1 by our lab, support for a glial axis of dopaminergic regulation is mounting. In this proposal, I will use transgenic mouse models to investigate the determinants of microglial DRD1 expression and how it impacts the neuronal response in two instances of sustained changes in dopamine levels: juvenile dopaminergic development and chronic cocaine.